CTSA K12 Program at the University of Michigan

Project Summary/Abstract
The Michigan Institute for Clinical & Health Research (MICHR) career development programs have provided
innovative and impactful clinical and translational research training and support to more than 90 diverse
multidisciplinary scientists since 2017 who have continued on to make important scientific discoveries. Over
the past 15 years our alumni have authored more than 3300 scientific papers that have generated more than
53,000 social media remarks and been included in 240 policy documents. They have also received more than
$400M in research grant support. Our scholars have emerged as translational science leaders and influential
mentors for those following their path as they lead translational research programs at the national level. Their
efforts have contributed to solving some of the nation's most vexing health challenges ranging from basic drug
and genomic discovery to policy research addressing health disparities and the opioid crisis. MICHR's K12
program is continually strengthened through our robust evaluation platform, which integrates critical feedback
from multiple stakeholder groups to implement new competency-based educational initiatives. Our outstanding
program faculty, all of which have undergone mentor training, welcome our K12 scholars into their highly
successful research programs (more than $90M in extramural funds). The new MICHR K12 program will
support 11 scholars annually, who are at a senior postdoctoral fellow or early faculty level, by providing new
programmatic initiatives to support institutional transformation regarding the often invisible but pervasive
patterns that disproportionately alter careers for those underrepresented in their fields (i.e., the hidden
curriculum). Through the following areas of thematic focus, we will support each K12 scholar for two to three
years as they work to gain translational research independence during their time in our program: 1) Fortify
career trajectories with precision preparation in translational science and research; 2) Accelerate translation by
preparing scholars to best utilize scientific social networks; 3) Prepare scholars to be versatile communicators
who lead effective research teams and become science advocates. Our expected outcome is a K12 program
that better prepares and equips scholars for long-term successes in conducting translational research and
science, particularly after leaving our program as they secure external research support. Moreover, these
efforts will motivate change in pervasive patterns that can alter scholars' long-term success as they work to
become translational science leaders in their fields. These efforts will also allow us to continue MICHR's legacy
of building strong leaders within diverse research scientific communities that impact human health.

Public health relevance
Project Narrative The CTSA K12 Program at the University of Michigan will build upon its history of innovative and impactful clinical and translational career development programs by providing new programmatic initiatives to support institutional transformation regarding the often invisible but pervasive patterns that disproportionately alter careers those underrepresented in their fields (i.e., the hidden curriculum). These efforts will also allow us to continue MICHR's legacy of building strong leaders within diverse research scientific communities that impact human health, ranging from basic drug and genomic discovery to policy research addressing health disparities and the opioid crisis.